PORPHYRIN NUCLEIC ACID INTERACTIONS

We have prepared hybrids containing an alkylporphyrin covalently embedded in oligodeoxynucleotides via oxypropyl linkers to the phosphate groups of the backbone. These have allowed us to study interactions between a porphyrin similar in structure to common cofactors; found in nature and DNA. (Previous work in this field has almost exclusively been performed with xenobiotic meso-tetraarylporphyrins). A series of NMR spectra at different temperatures were recorded of the sequence 5'-CGCGCCTTC-P-CATTGCGG-3', where -P- denotes the porphyrin, complexed with a complementary DNA strand bearing a thymidine residue at the site facing the porphyrin. This duplex had been selected as the most stable among a number of different complexes. The spectra acquired on the FBML's 500 MHz spectrometer have allowed us to derive qualitative structural information about the porphyrin-DNA interactions. Together with other spectroscopic and footprinting data, the temperature-dependent NMR data have allowed us to propose herniintercalation of the macrocycle as the most likely structural consequence of the porphyrin-DNA interactions.